National Center for Foundational Artificial Intelligence for Rehabilitation (FAIR Center)

Artificial intelligence (AI) is transforming society by enabling advances in computer vision, natural language
processing, and several areas of biomedical research. Some modern AI models have become so powerful they
have been dubbed “Foundation Models.” Unfortunately, rehabilitation researchers and people with conditions
that limit mobility have yet to see much benefit from modern AI, and no foundation model exists for
rehabilitation. Our Center for Foundational Artificial Intelligence for Rehabilitation (the FAIR Center) will
establish a vital research program to enable rehabilitation scientists to apply state-of-the-art AI to diagnose,
monitor, and improve the outcomes of rehabilitation. We have created a large-scale, high-quality dataset of
movements and rehabilitation outcomes, the FAIR Dataset, and tools to automatically integrate data from many
research studies, which is vital for the field and the research we propose. The FAIR Center will:
1. Develop and validate a Foundation AI model for Rehabilitation (the FAIR Model) and use the model to
address important rehabilitation research questions. The FAIR Model will be trained and tested with our
FAIR Dataset and leverage a state-of-the-art generative machine learning architecture. We will apply the
model to (a) develop a video-based metric to predict ACL injury, (b) personalize gait retraining for
individuals with knee osteoarthritis, and (c) predict surgical outcomes for children with cerebral palsy.
2. Disseminate, support, and enhance the FAIR Dataset and FAIR Model through easy-to-use web interfaces,
training materials, and open-source code.
3. Engage thousands of rehabilitation scientists, engineers, and people with lived experience in a community
that uses data science for rehabilitation research via training and community-building programs.
4. Establish a cohesive, vibrant, and sustainable Medical Rehabilitation Research Center through the
leadership of an experienced executive team, external advisors, and people with experience living with
mobility-limiting conditions.
By providing high-quality software, data, and AI models, the FAIR Center will enable collaboration of
unprecedented scale between bioengineers, clinicians, computer scientists, people with lived experience with
mobility-limiting conditions, and others focused on rehabilitation. Our training efforts will create a new
generation of rehabilitation scientists who are fluent in the strengths and challenges of AI. Our Center will be
run by a tightly integrated clinical and engineering team, enabling us to appreciate the goals of people with
lived experience, recruit participants to our studies, and rapidly create and share valuable new technology.
Together with the FAIR Center community, we will achieve the potential of AI to understand and improve
human movement, and increase ability for people with osteoarthritis, cerebral palsy, and many other
conditions.

Public health relevance
Millions of people suffer from pain and loss of independence due to conditions like osteoarthritis, cerebral palsy, stroke, and age-related frailty, which limit their ability to move. Although vast amounts of data have been collected by hundreds of movement research labs, these data remain siloed in isolated labs and have been minimally utilized to understand and improve the rehabilitation of individuals with these conditions. Our project will overcome this barrier by curating a high-quality, large-scale dataset to characterize human movement, and developing powerful tools that leverage artificial intelligence (AI) to revolutionize how we diagnose, monitor, treat, and prevent conditions that impair human movement.